EFFECT OF DIET ON INTRAVENOUS GLUCOSE TOLERANCE TESTING IN NORMAL SUBJECTS

The purpose of this project is to ascertain which factors significantly affect insulin response to IVGTT, to standardize pretest and test conditions, and to derive reference values for use in studies aimed at prevention of IDDM.